Mechanisms underlying sex differences in allergen- and RSV-induced airway inflammation after in utero allergen exposure.

PROJECT SUMMARY
Asthma is a common chronic disease among children and is a significant cause of morbidity. As children,
males have a higher incidence and prevalence of asthma compared to females at a 2:1 ratio. Yet, it is unknown
why there is a sex disparity in asthma prior to the upregulation of sex hormones during puberty. Maternal
asthma is a risk factor for childhood asthma, suggesting an in utero effect. Additionally, infection with
respiratory syncytial virus (RSV) during the first year of life is also associated with increased risk of developing
childhood asthma. The sex difference in airway inflammation in childhood asthma may be regulated at the
intersection of genes and environmental exposures, but the mechanisms are unknown. My proposal will
determine the mechanistic role of in utero allergen exposures and sex chromosomes in early-life immune
responses to respiratory syncytial virus (RSV) infections. I have developed a mouse model of in utero
exposure to house dust mite (HDM) allergen followed by RSV infection with 01/2-20 clinical isolate (3x107
PFU/ml) in male and female pups to answer this question. My preliminary data shows that, following infection
with RSV, male pups exposed to in utero HDM had increased IL-13+ CD4 T cells and a decreased ratio of
Tregs to Th2 cells compared to in utero HDM exposed RSV-infected female pups. Additionally, in
bronchoalveolar lavage (BAL) fluid I determined an increased trend (p<0.08) of eosinophils in male pups
exposed in utero to HDM following RSV infection compared to females. These results show sex differences in
airway inflammation and Treg numbers following in utero exposure to allergen, providing a potential
mechanism for the sex disparity in childhood asthma prevalence and severity. Based on these data, I
hypothesize that in utero exposure to allergen increases airway inflammation and drives Treg instability and
dysfunction in males more than females. I will test my hypothesis using mechanistic approaches that examine
the differential contributions of sex chromosome dosages versus sex hormones to airway inflammation by
using the “four core genotypes” (FCG) mice. FCG mice allow for XY phenotypic females and XX phenotypic
males due to mutations in the Sry gene on the Y chromosome. In this proposal, I will: (Aim 1) Elucidate how
the X chromosome restricts RSV-induced airway inflammation in pups exposed to allergen in utero, and (Aim
2) Determine how the X chromosome increases Foxp3 expression and Treg suppressive function in pups
exposed to in utero allergen. Understanding how allergens and sex chromosomes impact immune-mediated
responses in early life is critical for generating new prevention and treatment approaches that target the early
life immune system in utero and postnatally.

Public health relevance
PROJECT NARRATIVE Boys are two times more likely to have childhood asthma than girls, and it is unknown whether maternal asthma contributes to this sex difference. This proposal will determine the mechanisms by which in utero exposures and sex chromosomes regulate anti-viral and allergic immune responses in male and female pups. My findings will elucidate foundational mechanisms underlying sex differences in childhood asthma and provide the critical research training I need to be a successful OBGYN physician-scientist.